Leveraging Psychological Autopsies to Accelerate Research into Stimulant Overdose Mortality

Project Summary/Abstract
Drug poisoning (aka “overdose”) is a complex construct, particularly for stimulants. While opioid overdose is
generally caused by respiratory depression, stimulant overdose is multi-faceted. Non-fatal events are likely
driven by cardiac and psychiatric complaints. However, fatal events are less well understood. Psychological
autopsies have been shown to be immensely valuable in understanding opioid overdose deaths, identifying
many of the key elements of overdose that still drive overdose prevention efforts today, and we propose to
leverage that mechanism to accelerate our understanding of and response to stimulant overdose mortality. For
example, cardiac disease has previously been identified as more common among stimulant overdose
decedents than heroin overdose or suicide-by-hanging. However, the majority of stimulant overdose deaths
lack an additional medical explanation. With psychological autopsies, we can leverage not just medical
examiner data, but also medical records and informant interviews to identify cardiac disease and complaints
antecedent to death. This approach, responsive to Objective 2 of the RFA, also allows for a detailed
understanding of the intent of overdose (i.e. suicidality), as well as an opportunity to determine the
intentionality of fentanyl use in stimulant/fentanyl overdose events. We will identify 100 stimulant overdose
decedents (divided among cocaine, methamphetamine, and cocaine or methamphetamine with fentanyl),
conduct informant interviews (including scales and qualitative data), and gather data from the post mortem
investigation (e.g., vital records, toxicology, autopsy, case narrative, death scene photographs) and medical
record abstraction. Subsequently, we will conduct qualitative interviews with 40-60 living people who use
stimulants (half MA, half cocaine) to explore elements of resilience and risk reduction strategies.

Public health relevance
Project Narrative Death from acute stimulant toxicity (“overdose”) is rapidly rising across the United States. While there are decades of research and program development undergirding opioid overdose prevention, there is minimal understanding of the nature of stimulant overdose mortality. This study of stimulant overdose mortality will utilize psychological autopsies to accelerate our understanding of the antecedents to death, as well as the role of fentanyl. Based on the results, living people who use stimulants will be interviewed to explore resilience and risk reduction strategies that correspond to an enhanced understanding of the etiology of stimulant overdose death. This study aims to contribute to the eventual design of interventions to reduce stimulant overdose mortality.